Deconstructing food parenting approaches to obesity prevention for the highly food motivated child

PROJECT SUMMARY
High levels of food motivation among young children are heritable, track over time, and associated with
elevated risks of unhealthy eating and obesity. Despite significant growth of family-based obesity prevention
efforts, the evidence base is remarkably scant on parenting highly food motivated children to prevent obesity
and poor dietary outcomes. The need to move away from a “one-size-fits-all” approach to food parenting is
particularly pronounced for children from racial and ethnic minority families with low income that experience
greater disparities in obesity, are underrepresented in the food parenting and family-based prevention
literatures, and for whom prevention efforts have had limited success to date. Our goal is to generate a
robust basic science evidence for parenting highly food motivated children to prevent excessive
dietary intakes and body mass index (BMI) gains during the preschool years among racial/ethnic
minority families with low incomes. Using a prospective cohort design, we propose to follow 450 Hispanic
and Black caregiver/child dyads with low incomes at three time points as children transition from preschool to
elementary school, when significant numbers of children begin to experience problems of poor diet quality and
obesity. We will recruit children with varying food motivation to understand whether highly food motivated
children have different needs than other children. We propose a multi-method approach using state-of-the-art
measures, including ecological momentary assessment, to comprehensively investigate the amount, types,
and consistency of food parenting practices (i.e., specific, goal-oriented behaviors) needed to prevent food
motivated behaviors, excessive dietary intake, and BMI gains in children. Specifically, we propose to
comprehensively evaluate the role of structure (i.e., theoretically supportive) and its differentiation from more
coercive types of food parenting control. Aim 1 will characterize multi-dimensional eating behavior profiles and
obtain evidence of validity via associations with observed food motivated behaviors, excessive dietary intakes,
and BMI gains over 2 y. Aim 2 will evaluate the amount, type(s), and consistency of food parenting structure
needed to prevent food motivated behaviors, excessive dietary intakes, and BMI gains among highly food
motivated vs. other children over 2 y. Aim 3 will evaluate whether structured food parenting practices are more
beneficial in the context of global approaches to feeding or feeding styles that involve high levels of control
(i.e., authoritarian) vs. more balanced styles (i.e., authoritative). Findings will 1) generate a basic science
evidence base on food parenting approaches for highly food motivated children that currently does not exist, 2)
provide greater specificity for family-based prevention efforts, and 3) support equity in prevention by
representing populations who experience greater disparities, are underrepresented in research, and for whom
prevention efforts have had limited success.

Public health relevance
PROJECT NARRATIVE High food motivation among children is trait-like and increases risks of unhealthy dietary intake and obesity. Scientific knowledge of how parenting can best support healthy eating habits and growth among children who are predisposed to overeating is surprisingly limited. This investigation will provide the first comprehensive evidence of supportive food parenting approaches for obesity prevention that address the needs of highly food motivated children.